Temperature and thermogustatory preferences

Project Summary
Flavor is associated with food selection and preference behaviors in humans. Flavor is contributed by taste,
olfaction, and somatosensory sensations such as food temperature. During food sampling, cooling sensations
frequently accompany taste experiences in the mouth due to the high resting temperature of intraoral skin. Yet
compared to taste biology, there are wide, significant gaps in our understanding of how temperature sensing
impacts ingestive preferences and behavior. A goal of the proposed studies is to begin to define how thermal
sensations and receptor mechanisms participate in orosensory-guided preference and ingestive responses in
mice. This is a mostly unexplored area of study critical to flavor neurobiology. For behavioral tests, we have
engineered an adapter that independently varies the temperatures of fluids inside multiple sipper tubes
presented individually to mice by a lickometer. When coupled with this adapter, the lickometer can perform
brief-access fluid licking tests that gauge how oral temperature sensations influence sensory/tongue control of
mouse licking behavior. Using our thermo-lickometer, Aim 1 will study how thermal sensations mediated by the
transient receptor potential (TRP) melastatin 8 (TRPM8) cold receptor found on trigeminal fibers contribute to
orobehavioral responses to cooling temperatures. To do this, we will evaluate if mice gene-deficient for TRPM8
show impaired innate and conditioned licking responses to chilled water compared to wild-type. Studies will
ask if TRPM8 input is necessary for mice to behaviorally separate oral cooling sensations from warm
temperatures that our pilot data show are avoided when sensed in the mouth. Aim 2 will study how oral thermal
sensing by TRPM8 impacts taste preferences. We will gauge if cooling temperatures that excite TRPM8
complement and counter preference and avoidance of sweet and bitter taste stimuli by comparing brief-access
licking to temperature-controlled tastes between control and TRPM8 deficient mice. Aim 3 will measure brief-
access licking of temperature-controlled fluids in mice with silenced trigeminal thermosensory afferents or
ablation of taste bud cells that express temperature-sensitive receptors. Oral temperature can also excite taste
neurons (thermogustation) albeit the function of this has been unknown. Thermosensory afferent mechanisms
will be evaluated using mice deficient for TRP vanilloid 1 (TRPV1)-lineage afferents, broadly mediating
thermosensation, and mice with conditionally silenced TRPV1-positive trigeminal ganglion neurons, which
convey orofacial thermal and nociceptive signals. Thermogustatory mechanisms will be probed using mice
deficient for a protein that regulates the development of taste bud cells with temperature-sensitive molecular
effectors. Altogether, these studies will provide an initial account of how thermosensory and thermogustatory
processes influence ingestive behaviors. Ultimately, defining the role of oral temperature sensing in intake
behavior will be critical for understanding causal relationships between flavor and ingestive conditions.

Public health relevance
Project Narrative The proposed research aims to define how thermal sensations and thermoreceptor mechanisms inside the mouth affect ingestive and taste-guided behavior. Understanding these concepts will be important for delineating how sensory mechanisms involved with flavor influence ingestive decisions that impact nutritional status and health.